Relationship of autonomic nervous system function on functional brain networks during normal drinking and abstinence in daily drinkers

Project Summary
Alcohol abstinence is a key feature of the drinking experience, and relapse – by definition – is shifting from an
abstained state to consumption. Many questions remain unanswered in the literature regarding the physiological
mechanisms and neural signatures of abstinence, and understanding these substrates will be essential for developing
prevention and treatment studies for Alcohol Use Disorders (AUD). The focus of the F99/K00 proposal is an investigation
of central and autonomic nervous system effects associated with alcohol abstinence – in essence, how the brain
responds to a period of imposed abstinence and how autonomic function impacts those responses. Before we can
understand how neural processes associated with abstinence contribute to relapse in AUD patients, we need to
understand what comprises a typical response, and the range of potential responses in otherwise healthy drinkers.
Typically, physiological research examining alcohol drinkers focuses solely on brain function, discounting the
interplay between central and peripheral nervous system measures. This study examining autonomic nervous system
function, through the peripheral metric Heart Rate Variability (HRV), in addition to examine differences in functional
brain network organization in everyday drinkers during a period of typical alcohol consumption and a period of
abstinence. By examining the relationship between these central and peripheral measures, this study aims to capture a
more complete understanding of the neurobiology associated with alcohol abstinence.
At the time of this submission, the applicant, under the guidance of the sponsor, has completed all research
design and data collection relevant to the study. Still remaining are analyses investigating the relationship between HRV
and functional brain network connectivity during alcohol cue exposure following abstinence (F99 Phase), which will
require hands‐on and didactic training analyzing HRV and brain network data. Following the completion of the F99
portion of this proposed project, the study will be expanded during a postdoctoral following to include more advanced
analyses of brain network and HRV dynamics (K00 Phase).

Public health relevance
Project Narrative The study proposed in this F99/K00 application investigates the relationship between Heart Rate Variability (a measure of autonomic nervous system function) and brain states in healthy, moderate to heavy daily alcohol drinkers following periods of typical consumption and abstinence. To date, the study design has been completed and all data collected, with preliminary analyses run. The F99 phase of the project will involve the remaining analyses investigating connectivity changes with and outside of the Default Mode Network across drinking states, while future directions of the project, to be conducted during a postdoctoral fellowship and the K00 phase of this fellowship, will include more advanced dynamic assessments of brain states using functional networks.